Safety and Health for Home Care Aides in Healthcare and Social Assistance: The Safe Home Care Intervention Study

PROJECT SUMMARY/ABSTRACT
This resubmission of a competitive renewal application for NIOSH PAR-18-812, addresses the NORA sector
Healthcare and Social Assistance and NORA cross-sectors: 1) musculoskeletal health, 2) respiratory health, 3)
infectious disease prevention, and 4) traumatic injury prevention. The long-term goal of the study is to protect
the occupational safety and health (OSH) of home care (HC) aides. Due to the rapidly aging population, HC
aide jobs are among the fastest growing occupations. There is increasing evidence that aides experience
many serious OSH hazards to which they are particularly vulnerable because they are low-wage workers and
yet there are few HC OSH intervention studies. A major challenge for HC OSH is that the employer has limited
control over the work environment because it is a home. To address these challenges, the proposed
intervention study will engage HC employers and case managers (CMs), clients and their families, in changing
the home-work environment to reduce hazards for HC aides. The overall objectives are to evaluate the
effectiveness of interventions and the implementation process and to translate findings to reduce OSH
hazards, illness, and injuries among HC aides. The study builds on a highly productive, multidisciplinary
research team working with an extensive, active industry-labor-public health-elder services partnership
network. Central hypotheses are a) HC aide OSH hazards can be reduced by clients and families with
assistance and tools from HC employers and CMs introduced during a client’s home assessment; and b) the
interventions will lead to fewer OSH hazards to HC aides. Mixed methods with a research-to-practice (r2p)
approach will be used to accomplish specific aims to: 1) Develop OSH interventions and an implementation
process to reduce OSH hazards to HC aides; 2) Evaluate the extent to which changes in the home
environment by HC clients can reduce the OSH hazards of the aides who visit them by: 2a) implementing OSH
hazard interventions and 2b) evaluating the interventions’ effectiveness; 3) Evaluate the intervention
implementation process; and 4) Translate and disseminate findings via the HC partners. The approach is
innovative because it aligns aide and HC client safety; targets a new, potentially powerful leverage point for HC
OSH interventions; and seeks to expand OSH into the delivery of elder HC services. It is significant because it
aims to reduce OSH hazards, injuries and illnesses among HC aides, a large, low-wage workforce. OSH
hazards are also increasingly becoming a burden on HC employers. Expected outputs: evidence-based
interventions consisting of activities, tools, and training to reduce OSH hazards for HC aides; lessons learned
about how to engage HC clients and families in aide OSH. Expected outcomes- immediate: a reduction in HC
aide OSH hazards; intermediate: increased awareness of aide OSH preventive measures among HC clients;
incorporation of HC aide OSH in elder services and policies; new knowledge in OSH community about
effective HC interventions. Long-term: a healthier, more stable HC workforce to care for our aging population.

Public health relevance
PROJECT NARRATIVE The proposed intervention research is relevant to public health because it will promote the health of home care (HC) aides, a low-wage, socially diverse population that provides health and social services to elders and people with disabilities. The project is relevant to the mission of the National Institute for Occupational Safety and Health because it will develop methods for preventing exposure to hazardous conditions in the workplace and translate findings into prevention practices and products to reduce work-related illness and injuries.